Translational study of RAGE-SIRT1 therapy for arteriovenous fistula maturation

Objective: In this translational research proposal, our first goal is to determine the roles of the receptor for
advanced glycation end-products (RAGE) and sirtuin-1 (SIRT1) in endothelial cells (ECs) in arteriovenous fistula
(AVF) maturation failure. Our second goal is to determine the efficacy of small-molecule RAGE inhibitors and
SIRT1 activators in improving AVF maturation.
Hypothesis: Disturbed blood flow increases RAGE and decreases SIRT1 in ECs, leading to DNA damage
and senescence-associated secretory phenotype (SASP) to cause AVF maturation failure.
Background: AVFs are surgically created by anastomosing a vein to a nearby artery directly, exposing the
fistula vein to highly disturbed blood flow. Successful AVF maturation occurs through sufficient lumen expansion
to increase AVF blood flow. The inability of AVFs to mature is a major clinical problem confronting chronic
hemodialysis. Up to 60% of newly created AVFs fail to mature, and currently, there is no proven effective strategy
to enhance AVF maturation. Our proposal is supported by novel and strong preliminary work from our research
team pointing to a causal role of DNA damage and SASP in poor AVF remodeling, following the differing effects
of disturbed flow on RAGE and SIRT1 in ECs.
Aims: Aim 1 is to demonstrate the causality of endothelial RAGE and SIRT1 in DNA damage, SASP, and
AVF outcomes in mice. Aim 2 is to elucidate the crosstalk between RAGE and SIRT1 in disturbed flow-induced
DNA damage and SASP in endothelial cells. Aim 3 is to demonstrate the efficacy of RAGE inhibitors and SIRT1
activators in decreasing DNA damage and SASP and improving AVF outcomes in mice.
Research Design: We will use a combination of animal and cell studies. Animal studies will use both genetic
and pharmacological approaches to investigate how RAGE inhibition and SIRT1 activation affect AVF
remodeling in mice of old age with chronic kidney disease. Cell studies will use a unique dynamic co-culture
model to elucidate the crosstalk between RAGE and SIRT1 in cells of old age under AVF-mimicking disturbed
flow, with a focus on DNA damage and SASP response.
Significance: The knowledge gained by completing the proposed aims will help to identify novel
pharmaceutical targets for the prevention/treatment of AVF maturation failure, particularly in Veterans of older
age.

Public health relevance
The goal of the proposed research is directly relevant to the VA’s commitment to delivering high-quality, cost- effective hemodialysis care to Veterans with end-stage kidney disease (ESKD). The prevalence of ESKD is higher in the Veteran population than the general U.S. population (604 vs. 187 per 100,000, respectively), and over 80% of Veterans with ESKD utilize hemodialysis as their primary renal replacement modality. The arteriovenous fistula (AVF) is the preferred mode of vascular access. However, many AVFs do not mature to become useful for dialysis, resulting in numerous interventions to promote maturation and complications from prolonged hemodialysis catheter use. This proposal will improve our understanding of the pathophysiology of AVF maturation failure, which will potentially lead to new therapies for this clinical problem and ultimately improve morbidity and mortality for the VA ESKD patients requiring hemodialysis therapy.